Leadership Administrative Core

The role of the Leadership Administrative Core (LAC) is to integrate and unify the multiple, interdisciplinary
components of the Brigham and Women’s Hospital/Harvard Medical School (Brigham/Harvard) Center
for Stress and Neural Regulation of Reproductive Aging Health Outcomes. The Brigham/Harvard SCORE
LAC will provide scientific, administrative, and fiscal oversight of our SCORE Projects, Career Enhancement
Core, and Sleep Resource Core, and will catalyze progress and innovation in women’s health and sex-
differences research across the Brigham/Harvard SCORE environment. The LAC will be co-led by Hadine
Joffe, MD, MSc, and JoAnn Manson, MD, DrPH, who serve as Executive Director and Scientific Advisor,
respectively, for the Connors Center for Women’s Health and Gender Biology. The Connors Center is the
leading women’s health research center at Brigham and Women’s Hospital (BWH) and Harvard Medical
School (HMS), responsible for coordinating interdisciplinary and cross-departmental women’s health and sex-
differences investigation. Drs. Joffe and Manson, both internationally recognized leaders in women’s health,
are long-time collaborators whose complementary scientific expertise covers the reproductive aging health
outcomes highlighted in this proposal: vasomotor symptoms (VMS), sleep disturbance, cardiometabolic,
cognitive, and other characteristics of the menopause transition that may influence dementia susceptibility in
aging women. A strength of this proposal is that it builds on and expands the research focus, lead
investigators’ interdisciplinary collaborations, and career enhancement programs that are foundational to the
Connors Center. The LAC will draw upon the wealth of resources from existing collaborations and scientifically
aligned women’s health programs at BWH and HMS, specifically those focused on sex differences, sleep,
cardiometabolism, and brain health, including dementia, in women. By leveraging both the robust infrastructure
of the Connors Center and that of other BWH and HMS research programs and initiatives, we expect a rapid
and seamless initiation and implementation of our Center’s scientific and programmatic activities. Fortified by
the guidance of key External and Internal Advisory Boards, an Expert Scientific Panel and a Steering
Committee, the Brigham/Harvard SCORE LAC will provide dynamic scientific and administrative oversight,
internal coordination, and external engagement with the broader SCORE research consortium necessary for
productivity to flourish, leading to a fully-integrated, translational program of women’s health and sex-difference
research.

Public health relevance
LEADERSHIP ADMINISTRATIVE CORE NARRATIVE The Leadership Administration Core (LAC) will oversee the scientific agenda and administration of the research Projects, Career Enhancement Core, and Sleep Resource Core of the Center for Stress and Neural Regulation of Reproductive Aging Health Outcomes. The LAC will also ensure engagement of the Brigham/Harvard SCORE with the broader SCORE research consortium. The LAC will support investigators in achieving the translational aims outlined in the respective Projects and Cores. Our overarching goals are to advance our understanding of stress exposures and neural regulation of reproductive aging health outcomes and catalyze the growth of interdisciplinary and translational women’s health and sex-differences research.